Sample Processing and Immune Assessment

Project Summary
The purpose of Core 2 is to provide a centralized laboratory resource for processing, cryopreserving and
distributing patient samples and to monitor the kinetics of immune reconstitution following allogeneic
hematopoietic stem cell transplantation (HCT). Prior to transplantation, peripheral blood mononuclear cells
(PBMC), bone marrow and serum or plasma are obtained from all patients enrolled on clinical trials supported
by this Program Project. PBMC, plasma and serum are also obtained from normal stem cell donors. Following
HCT, additional samples are obtained at regular intervals. All of these samples are processed, cryopreserved,
entered into a computerized inventory and made available to Program investigators. Patient confidentiality is
maintained at all levels and samples are only be obtained from patients who have provided informed consent.
To support clinical trials and laboratory studies in each project, Core 2 also provides a series of phenotypic and
functional immune assays that are used to monitor the effects of different immunologic interventions. Results of
each of these assays are provided to Dr. Kim (Biostatistics – Core 1) for correlation with laboratory studies in
each project as well as with clinical outcomes.

Public health relevance
Project Narrative Core 2 is responsible for obtaining blood and marrow samples from patients and stem cell donors prior to transplant and at defined times after transplantation. These samples are processed and banked and made available to program investigators for specific studies outlined in their projects. Immunologic assays performed in this core will also be used to characterize the effects of therapeutic interventions designed to reduce relapse and treat GVHD.